Mechanisms for Impaired Adaptation to Aerobic Exercise with Metabolic Disease

PROJECT SUMMARY/ABSTRACT
Exercise capacity, also known as cardiorespiratory fitness, has emerged as one of the single best predictors of
health and longevity. Low exercise capacity is a strong risk factor for the development of cardiovascular
disease and overall mortality. Aerobic exercise training is the only effective treatment to increase exercise
capacity and reduce the health risks associated with low exercise capacity. However, even when levels of
physical activity are matched, exercise capacity remains lower in people with metabolic diseases such as Type
1 and Type 2 diabetes compared to those without metabolic disease, suggesting a phenotype of “low response
to training”. The goal of this investigation is to determine the mechanisms that contribute to low response to
training in metabolic disease, and develop treatment strategies to improve the response to exercise. Clinical
investigations and our data from animal models suggest that chronically high blood glucose levels (i.e.
hyperglycemia) may be a cause for low response to training by blunting beneficial adaptations that normally
occur with exercise in tissues like skeletal muscle. We hypothesize that hyperglycemia causes glycation and
accumulation of the extracellular matrix (ECM) in muscle, and in turn, these glucose-induced ECM alterations
can prevent tissue remodeling with exercise in 3 distinct ways: 1) Altering muscle signal transduction via a
newly discovered JNK/SMAD mechanical signaling axis; 2) Impairing the function of muscle progenitor and
endothelial cells; and 3) Reducing levels of circulating ECM remodeling proteins. One specific aim is to
determine whether blood glucose lowering treatments can improve exercise capacity and muscle remodeling in
response to exercise in animal models of metabolic disease. A second aim is to determine the cellular and
molecular mechanisms in muscle that contribute to low exercise response under conditions of hyperglycemia.
Finally, we will use advanced proteomic screening combined with in vitro methodology to identify circulating
mediators of low response to training in humans subjects. Hyperglycemia is becoming more common as rates
of metabolic disease rise globally. This may lead to a population that is increasingly resistant to improved
exercise capacity with training, and the associated reduction in health risk. Despite significant clinical evidence
linking chronic hyperglycemia to the “low-response to training” phenotype, little is known about the molecular
mechanisms underlying these associations. This project will significantly advance our understanding of the
mechanisms that cause low response to training in people with metabolic disease, and identify treatments to
improve exercise capacity, health span, and longevity.

Public health relevance
PROJECT NARRATIVE Low exercise capacity is one of the strongest predictors for the risk of chronic disease and mortality. However, improvements to exercise capacity in response to exercise training can be blunted in people and animal models with hyperglycemia; a condition that is becoming increasingly prevalent as rates of metabolic disease rise globally. This study will determine the cellular and molecular mechanisms for low response to exercise training associated with hyperglycemia, and test specific therapies to improve exercise capacity, which may ultimately lead to better health and increased lifespan.